How do you build an astrocyte?

Project Summary
Astrocytes are crucial regulators of brain development and function. Astrocytes acquire a remarkably complex morphology
that allows them to associate with each other, other cell types (e.g. the vasculature) and synapses where they regulate
synaptogenesis, neurotransmitter reuptake, metabolic support, ion balance, and ultimately animal behavior. While it is
believed that the elaborate morphology of astrocytes is absolutely essential for efficient astrocyte function, how astrocytes
acquire this unusually complex architecture remains poorly defined. This is surprising in light of their crucial roles in neural
circuit formation and function, and the fact that disruption of astrocyte growth control results in the most intractable and
deadly human brain tumor, glioblastoma.
How do astrocytes acquire their remarkably morphology, and how do they organize their subcellular architecture
to enable their diverse functions? We will attempt to answer these central questions using Drosophila astrocytes as a model.
Fly astrocytes are remarkably similar to their mammalian counterparts by morphological, developmental, molecular, and
functional criteria, and Drosophila offers a battery of powerful molecular-genetic tools with which to explore fundamental
questions in astrocyte biology that are not available in other organisms. We will begin by comprehensively characterizing
the cell-wide organellar landscape of astrocytes by examining the distribution of ~30 genetically encodable markers that
label cellular organelles (Aim 1). This will allow us to define, with single-cell precision, the basic organellar architecture
of astrocytes. This will be an essential first step toward understanding how their intricate morphology is arranged
ultrastructurally and how it may dictate, or be regulate by, their functions. These cellular landmarks will also enable a
rigorous analysis of mutants that affect astrocyte morphology. In Aim 2, we will perform the first unbiased forward genetic
screen for astrocyte growth control pathways. We have established a unique genetic screening platform for this purpose in
Drosophila based on MARCM technology, which allows for rapid screening with single-cell resolution for mutants that
alter a variety of phenotypes including cell morphology (growth, tiling, association with synapses), changes in proliferation,
or other changes in astrocyte properties. In preliminary work we have optimized our screening system, along with imaging
methods to maximally facilitate our work. This is part of a long term effort to understand how astrocytes are built in vivo.
Defining how astrocytes control their cell growth, infiltration, and tiling will be critical for us to gain a better understanding
how astrocytes affect brain health and disease. Since this will be the first forward genetic screen for astrocyte growth control
pathways, a wealth of exciting mutants await discovery. We will focus our subsequent efforts on pathways conserved in
mammalian astrocytes, and given the strong conservation of the developmental and functional properties in flies and
mammals, we expect our work will identify a number of new high-priority pathways for understanding astrocyte
morphogenesis in mammals.

Public health relevance
Project Narrative Astrocytes are a glial subtype that associate intimately with neural circuits and are essential for brain function, but we know very little about how they grow, form contacts with neurons, and regulate dynamic changes in morphology. A deep understanding of how astrocytes regulate their elaborate morphologies and associate with neurons will be essential to study their basic functions, and how dysregulated growth can occur in human disease. This proposal will use Drosophila to characterize the fine details of astrocyte subcellular architecture, and identify and characterize novel conserved signaling pathways regulating astrocyte growth, maintenance and function.